Development of Gaze Control for Integration of Language and Visual Information in Deaf Children

Project Summary / Abstract
Children learn words by connecting the language input they perceive to the objects and events in the world
around them. While hearing children perceive auditory linguistic input while simultaneously looking at objects,
deaf children learning sign language perceive both linguistic input and objects visually. Therefore, deaf children
must learn to strategically and swiftly allocate their visual attention to map language onto its referents. This
learning process is complicated by the fact that deaf children frequently have incomplete access to language:
despite gains in technology and interventions, spoken language is generally not fully accessible to deaf
children, and most deaf children are born to hearing parents who lack expertise in sign language. Together,
these factors place young deaf children at risk for significant delay in development of a full first language,
which has cascading consequences on later language, literacy, and academic outcomes. Thus it is critical to
identify how input and interactions with young deaf children can optimally support early language development.
The proposed project investigates word learning in deaf children learning American Sign Language (ASL), a
significant and growing subset of the deaf population. Word learning is a critical component of language
acquisition that enables children to map object and event labels with the surrounding world. The specific aims
of this proposal are to 1) define the temporal alignment of parent input and children’s attention that supports
word learning in deaf children; 2) identify the role of children’s dynamically shifting visual attention in word
learning; and 3) demonstrate how linguistic and referential cues support word learning. This project uses a
combination of naturalistic observations of parent-child interaction and behavioral and eye-tracking
experiments in which the timing of input and the combination of input cues are manipulated to determine which
contexts are most supportive of word learning in ASL. This project has broad theoretical implications. Current
accounts of joint attention are based almost entirely on spoken language interactions, but language input and
attention must be organized and timed differently when both language and attention are perceived in a single
modality. The proposed project will lead to an expanded, unified theoretical account of joint attention that
encompass word learning across modalities. This project also has direct translational implications for parents,
early intervention professionals, and teachers of deaf children. First, the proposed work seeks to identify
developmental benchmarks in children’s visual attention that support word learning, and these benchmarks
can serve diagnostic tools in evaluation. Seond, understanding the optimal input timing and cues that support
word learning can inform approaches to intervention for families with deaf children. The current project focuses
on deaf children acquiring ASL, yet the findings will be broadly applicable, in that visual cues provide critical
information for deaf children learning language across modalities.

Public health relevance
Project Narrative Deaf children learning American Sign Language (ASL) perceive both language input and information about the world through the visual modality, so they must learn to divide and allocate their visual attention between people and objects in order to learn new words. In the proposed project we will investigate how the timing of parent input relative to child attention supports word learning, and how deaf children learn to divide and allocate their visual attention to learn new words. Findings from this project will inform parents, teachers, and early intervention specialists working with deaf children by documenting optimal strategies to support word learning.